Bradley Hospital Integrative Research Laboratories

PROJECT SUMMARY/ABSTRACT
The proposed research facility will provide biomedical research facilities and opportunities for exceptional
state-of-the-art pediatric psychiatry research to Bradley Hospital, the nation's first psychiatry hospital
exclusively serving children and adolescents. The new Integrative Research Laboratories, located on the
campus of Bradley Hospital in East Providence, RI, will create a centralized facility for scientists and their
research activities on the hospital campus—steps away from patients who participate in science and who may
benefit the most from new discoveries. The proposed facility addresses four core needs: (a) centralizing
multiple research groups in a cohesive facility immediately accessible to Bradley's patient populations who
participate in research; (b) modernize and expand the capacities of our aging sleep and chronobiology
research facility; (c) build a state-of-the-science child and adolescent psychiatry oriented biomarkers and
biospecimen assessment and processing laboratory; and (d) create new joint-use assessment spaces that
combine the breadth of modern psychiatric research (e.g., observation studies, neurocognitive testing,
electrophysiological and psychophysiological recordings, neuromodulation) into a single facility to facilitate
dynamic science and new collaborations. We propose construction of a 13,856 square-foot facility that will
occupy the second floor of a new building on Bradley's campus (with excess capital costs secured from
Hospital and corporate funds). These new Integrative Research Laboratories will include: purpose-built 24-
hour-operational environmentally controlled sleep and circadian research suites, sample collection, storage
and analysis facilities, assessment rooms focusing on child, family, and group observation and research,
centralized performance testing laboratories, 3 purpose-built physiological labs (EEG, psychophysiology and
neuromodulation), ample instrumentation storage and freezer space, and dedicated fixed equipment to
facilitate research success. Together, this new facility will transform the research capacities of Bradley
Hospital, solving multiple long-standing challenges to our scientific endeavors. Research accomplished in
these laboratories will benefit the children and families in RI, greater New England, and across the nation by
enhancing knowledge and understanding of pediatric mental health. Our construction and design plan meets
the highest standards of modern facilities to ensure the long-term utility of this space. We note that the hospital
and corporate institution (Brown University Health) have pledged approximately $13.7 million to ensure the
viability of this biomedical research facility. Our new Integrative Research Laboratories facility will provide the
infrastructure to support Bradley Hospital as a national and international leader in child and adolescent
psychiatry research well into the 21st century.